EFFECTS OF ORAL FRUCTOSE ON HEPATIC GLYCOGEN SYNTHESIS DURING GLUCOSE INGESTION

The purpose of this study is to examine the role of a small amount of fructose in the promotion of liver glycogen synthesis.